Determining the role of a TENT5 family non-canonical polyA polymerase in Drosophila spermatogenesis

PROJECT SUMMARY/ABSTRACT
Translational repression and reactivation play critical roles in the development and homeostasis of multicellular
organisms. These processes have been best studied in oocytes, which are often generated but not fertilized for
weeks, months or even years. Studies of Xenopus oocytes have shown that translational repression and
reactivation of at least some mRNAs involves removal of the mRNA polyA tail and coupling with proteins for
storage, followed by regeneration of the polyA tail for translational reactivation after egg activation by
progesterone. The TENT2 family of non-canonical polyA polymerases has been linked to this process in
Xenopus as well as in other animals. In Drosophila melanogaster, mRNAs must also be translationally
repressed and reactivated during spermatogenesis. Our preliminary data shows that a member of a different
family of non-canonical polyA polymerases, TENT5 is required for spermatogenesis in Drosophila
melanogaster. TENT5 family members have been linked to spermatogenesis in mice and humans as well, but
the mechanisms are unknown. In D. melanogaster, as in vertebrates, spermatogenesis occurs in a syncytium
through meiosis and most of spermatid differentiation. We have generated a strong loss-of-function CRISPR-
Cas9 allele, TENT52-83 that affects the end of spermatogenesis, after meiosis, when the spermatids become
separated into individual cells, a process termed spermatid individualization. In this proposal, we describe our
plans to define the role of D. melanogaster TENT5 in spermatid individualization. In Aim 1, we will use in situ
hybridizations to determine the TENT5 expression pattern in the testes and use Gal4/UAS-based approaches
to knock down TENT5 in the germline or the soma. This approach will allow us to determine in which cell type
TENT5 is required. In addition, we will attempt to rescue the TENT52-83 phenotype with wild type and catalytic-
dead versions of TENT5, to determine if TENT5 requires its polyA polymerase catalytic domain for its role. In
Aim 2, we will examine the localization of proteins with known roles in spermatid individualization, whose
mRNAs might be targets of TENT5 polyadenylation. We will use established techniques to pinpoint the stage
at which TENT52-83 affects spermatid individualization. The results of these analyses are expected to lay the
groundwork for future studies to confirm TENT5 targets with single molecule fluorescent in situ hybridizations
and co-staining with TENT5 protein, as well as RNA immunoprecipitation, for instance, that will define the
mechanism by which TENT5 proteins function in spermatogenesis, including potentially in humans.

Public health relevance
PROJECT NARRATIVE In this project we will determine the role of the non-canonical polyA polymerase TENT5 in spermatogenesis in the fruit ﬂy Drosophila melanogaster. A TENT5 gene has been linked to infer�lity in human males and our research ﬁndings will increase our understanding about causes and treatment of human male infer�lity.